Multiphoton imaging of the juxtaglomerular apparatus

This study aims to explore the molecular mechanisms, physiological functional significance, disease and
therapeutic relevance of a radically new neuron-like function of the understudied but chief renal cell type of the
macula densa (MD). MD cells are traditionally known as specialized renal epithelial cells capable of sensing the
local tissue environment and releasing various chemical messengers to control renal and glomerular
hemodynamics via tubuloglomerular feedback, and renin release as their classic functions. In addition, our work
in the last grant cycle identified their novel function in endogenous kidney tissue remodeling and repair. However,
interesting new insights suggest neuron-like function of these cells. Preliminary work using unbiased intravital
multiphoton microscopy (MPM) of MD versus all other renal cell calcium responses uncovered neuron-like rapid
and regularly oscillating spontaneous calcium transients (pacemaker activity), coordinated cell-to-cell
propagation within the MD via long (>50 µm), axon-like cell processes that were entirely specific to MD cells.
Numerous neurotransmitters and systemic neuroendocrine hormones given locally or iv triggered robust and
specific MD cell calcium responses and increased afferent renal nerve activity. MD cell gene profile and tissue
enrichment analysis identified brain tissue specificity of MD cells, and the expression of numerous neuronal
markers including nerve growth factor receptor p75NTR (NGFR, the highest expressed growth factor receptor
in MD cells), and some of the major Alzheimer’s disease risk genes. These studies painted a paradigm-shifting
new picture of MD cells functioning as interoceptive neuron-like cells that form autonomous, nephron-level
neuronal networks in the kidney, sense the local and systemic environment, process and send signals to renal
and central effectors in the brain to maintain homeostasis. Our central hypothesis is that neuron-like MD cell
calcium and NGFR signaling play novel primary roles in physiological responses to control renal hemodynamics,
renin, and tissue remodeling (local interoception) and whole body homeostasis (systemic interoception). Further,
we hypothesize that alterations in the neuron-like functions of MD cells represent a novel, neurodegenerative
component in the pathogenesis of chronic kidney disease (CKD) and can be therapeutically targeted. This project
will use comprehensive experimental approaches including new transgenic mice with chemo and optogenetic
tools, in vivo MPM imaging including innovative 3-photon excitation, MD transcriptome analysis, bioinformatics,
in vitro MD cell culturing and models of CKD. The specific aims are to examine the role of MD cell neuron-like
calcium and NGFR signaling in (1) physiological responses of the JGA, (2) in the development and progression
of kidney disease, and (3) their therapeutic potential in CKD. These novel MD cell-specific molecular and
signaling mechanisms may be targeted in the future development of new first-in-class MD cell stimulating
therapeutic approaches for CKD.

Public health relevance
Relevance Kidney diseases are associated with significant comorbidities and mortalities and affect close to a third of the US population, yet their pathophysiology remains incompletely understood. Macula densa cells play pivotal roles in the maintenance of the normal structure and function of the healthy glomerulus and also in the development of glomerular injury in kidney diseases, yet their primary pathogenic role has been largely overlooked. We propose to study the role of macula densa cells and their neuron-like function in the normal and diseased kidney, and to develop new therapeutic approaches for glomerular kidney diseases.